EARLY SIGNALS OF THE TRANSITION FROM IMMUNE QUIESCENCE TO ACTIVATION IN THE LIVER ALLOGRAFT MICROENVIRONMENT AND IN THE CIRCULATION

PROJECT SUMMARY
Children with liver transplants who are maintained on low dose immunosuppression (IS) with ideal graft
function according to clinical, biochemical, and histological criteria seemingly enjoy a harmonious equilibrium
between the host immune system and the liver allograft. Reducing IS is a challenge that, for some but not all,
precipitates alloimmune activation that can result in graft injury. Understanding the mechanisms of how
allograft quiescence is sustained or lost when stressed is essential to walking the tightrope of too much versus
too little IS. Achieving this balance is particularly critical for children and their families who typically face many
decades of IS.
Previously, we conducted prospective multicenter trials of IS withdrawal in children with liver transplants
[WISP-R (NCT00320606) and iWITH (NCT01638559)]. We reported that, among allografts that appear normal
by standard histological evaluation, objective quantification of inflammatory load using multiplex
immunostaining accurately predicted the clinical outcome of success or failed IS withdrawal. The density of
various inflammatory cell populations mapped allografts onto an alloreactivity spectrum that extended from
quiescent to activated. Among inflammatory metrics, the density of immunologic synapses (iSYNs), defined as
a lymphocyte interacting with an antigen-presenting cell based on positional, morphometric, and molecular
metrics, was the best predictor of those who could withstand the perturbation of IS reduction and maintain
allograft quiescence. These findings drive our primary hypothesis that the number and nature of
interactions between intrahepatic immune cells constitutes the basis of liver allograft immunogenicity
and determines whether quiescence is maintained or lost when challenged by reducing IS.
iSYNAPSE proposes to conduct a multicenter, single-arm trial of 50% IS dose reduction for stable children on
tacrolimus monotherapy with healthy liver allografts. Previous trials confirm that liver transplantation provides a
unique context to safely study host and graft responses when their harmonious equilibrium is challenged by IS
reduction. Utilizing allograft biopsies collected at the beginning and end of the trial, we will deeply characterize
the liver microenvironment, precisely mapping the location, identity, state, and interactions of key immune cell
subsets combining state-of-the-art technologies for tissue interrogation into a targeted and integrated multi-
modal approach. These experiments will allow us to determine if the baseline phenotype and transcriptome of
the lymphocytes and the antigen-presenting cells participating in iSYNs and their changes after IS is reduced
differentiates participants who succeed versus fail IS reduction. Understanding the basic mechanisms of how
allograft quiescence is maintained or lost in response to a discrete challenge addresses a fundamental
knowledge gap in transplant immunobiology. The knowledge gained may accelerate the transition of IS
management from empiricism to evidence-based with broad implications for all organ transplant recipients.

Public health relevance
PROJECT NARRATIVE The transplant community lacks a clear understanding of the basic mechanisms by which the host immune system and a liver allograft achieves, sustains, and/or loses the harmonious equilibrium of the liver microenvironment that is required for optimal allograft health. Leveraging the immunological “buffering systems” unique to the liver allograft, we propose to discretely perturb the equilibrium by reducing immunosuppression and delineate whether and how allograft quiescence is maintained or lost. Our overriding goal is to deeply probe the allograft liver microenvironment utilizing state-of-the-art technologies to unlock the conundrum of “too much” versus “too little” immunosuppression that plagues the current clinical management of children with liver transplants.